Markers of Nephrotoxicity during treatment with Antibiotic Combinations: The MONACO clinical trial

PROJECT SUMMARY: Vancomycin (VN) and piperacillin-tazobactam (PT) are two of the most used
antibiotics to treat patients with severe infection. The emergence of data linking combined treatment with
VN+PT to acute kidney injury (AKI) is thus a major safety concern. AKI, the syndrome of rapid kidney function
decline, is associated with increased risk of death and a nearly 8-fold higher risk of chronic kidney disease.
Given these potential risks, many health systems have implemented initiatives to avoid VN+PT despite its
therapeutic utility. However, whether VN+PT is truly nephrotoxic remains uncertain due to the use of creatinine
– a functional biomarker with poor sensitivity and specificity for tubular injury – as the standard biomarker to
evaluate nephrotoxicity. Animal models of the interaction suggest that PT might actually reduce VN mediated
kidney injury when evaluated with non-creatinine biomarkers of kidney injury. Hypothesizing
associatedAKI represents pseudotoxicity–
that VN+PT
inhibition of creatinine secretion without kidney parenchymal injury
– we showed that VN+PT was associated with significantly increased creatinine concentrations, but not with
change in cystatin C (Cys-C), a kidney function biomarker unaffected by tubular secretion. Although these
results may have practice changing implications, the small sample size and observational design of the study
preclude definitive conclusions.
Beyond limiting our understanding of VN+PT associated AKI, the poor diagnostic characteristics of
creatinine precludes differentiation of VN nephrotoxicity from other types of AKI subtypes; and the delayed
change in creatinine relative to tissue injury limits the potential for mitigating AKI severity through timely
dosage adjustment. Although biomarkers directly reflective of cellular stress, cellular damage, and renal reserve
have shown promise in the context of critical illness or cardiac surgery, their utility for monitoring nephrotoxic
drugs remains unclear. We
central
handling;
molecular
will leverage our established acute care research infrastructure to examine two
hypotheses: 1) VN+PT associated AKI is a pseudotoxicity manifested by isolated effects on creatinine
and 2) the temporal dynamics of a broad panel of kidney biomarkers can be used to create a
signature of VN nephrotoxicity. randomized controlled trialWe will test these hypotheses in a
comparing VN+PT to VN+cefepime (CP) – two standard of care antibiotic combinations in acutely ill patients
with infection. We will obtain serial measures of biomarkers of kidney function and injury to examine
comparative nephrotoxicity. This proposal will provide definitive evidence on the heavily debated kidney safety
of the essential VN+PT combination. In addition, we will leverage a rich dataset of kidney biomarkers to
develop a molecular signature of VN nephrotoxicity, with the aim of establishing a new paradigm for kidney
function monitoring in patients treated with nephrotoxic drugs.

Public health relevance
PROJECT NARRATIVE: Although extensive epidemiologic evidence suggests combined treatment with vancomycin (VN) and piperacillin-tazobactam (PT) is nephrotoxic, no mechanism of interaction has been identified. Our prior research suggests the association may represent a pseudotoxicity – inhibition of creatinine secretion without toxic effects on the kidney. We will test this hypothesis in arandomized controlled trial comparing VN+PT to VN+cefepime (CP) – two standard of care antibiotic combinations in acutely ill patients with infection, with measurement novel measures of kidney function and injury to evaluate nephrotoxicity.